Dissecting an IL4Ra-dependent neuroimmune circuit in eosinophilic esophagitis

PROJECT SUMMARY/ABSTRACT: Eosinophilic esophagitis is a chronic food antigen-driven allergic
inflammatory disease associated with symptoms such as refractory pain. While esophageal eosinophilia is a
hallmark of the disease, there is often a disconnect between eosinophil levels and quality of life, as patients in
histological remission often have persistent symptoms. Thus, the mechanism of symptom development in EoE
is likely more complex than eosinophilic inflammation alone. Recent studies demonstrate that the function of
afferent nerves extends beyond their role of relaying nociceptive information back to the CNS. Sensory neurons
can directly sense IL-4 and IL-13, two influential cytokines in EoE pathogenesis. These have been shown to
activate nerves to produce factors that then modulate immune cell function. One such factor is insulin-like growth
factor 1 (IGF-1), which can regulate neuronal sensitization and pain. In allergic inflammation and asthma, IGF-1
has been shown to promote mast cell survival, regulate eosinophil levels, and cause proliferation of epithelial
cells. Taken together, evidence is emerging that the peripheral nervous system may contribute to allergic disease
pathophysiology as an intricate part of the innate immune response. But the role of the nervous system in EoE
pathogenesis has not received much attention. Preliminary data demonstrated that mice with experimental EoE
display elevated eosinophil levels, increased non-evoked pain, heightened sensory neuron innervation density
in the esophagus, and altered sensitivity of sensory neurons to noxious stimuli. Sensory neuron-specific deletion
of IL4Ra (IL4Ra-/-NaV1.8) reduced inflammatory gene expression, histological severity, eosinophil levels, and
innervation density in allergic animals compared to their wild-type counterparts. Additionally, the cell bodies of
esophageal afferents in the dorsal root ganglia (DRGs) in mice with experimental EoE express elevated IGF-1,
but is significantly reduced in allergic IL4Ra-/-NaV1.8 mice DRGs and esophagi. Mechanistically, IGF-1 levels have
been linked to IL4Ra activation in multiple cell types. Therefore, we will test the central hypothesis that the
activation of esophageal sensory neurons via IL4Ra during allergic inflammation drives increased nerve
hypersensitivity and subsequent inflammation via IGF-1 signaling. Transgenic, DREADD, and AAV
technology will be used to determine the role of sensory neurons on nociception and inflammation in
experimental EoE. Pain-related behavioral assays, in vivo calcium imaging of DRGs, and molecular analyses
(qPCR, flow cytometry, IHC, IF) of the esophagus will be conducted. Aim 1 will elucidate the role of peripheral
nociceptive neurons and their expression of IL4Ra in a murine model of EoE through chemogenetic
manipulation of esophageal neuron firing. Aim 2 will determine whether sensory-neuron derived IGF-1 is
necessary to increase esophageal hypersensitivity and inflammation in experimental EoE. This research
will be the first to assess the presence of a potential neuroimmune mechanism by which nerves contribute to
disease development and symptom severity via expression of IL4Ra and IGF-1 signaling, in EoE.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it identifies an IL-4 receptor allergen sensing circuit that regulates esophageal nociception and inflammation that will impact the clinical care of patients with Eosinophilic Esophagitis (EoE). This innovative proposal will explore the underlying role of sensory neurons in EoE pathogenesis with a focus on an IL4Ra-IGF1 dependent mechanism. This project is aligned with the priority of the National Institute of Allergy and Infectious Diseases to “conduct basic and applied research to better understand, treat, and prevent infectious, immunologic, and allergic diseases.”